Core-001

A vibrant translational informatics ecosystem requires technical and organizational engagement across the
research data lifecycle (data collection, storage, analytics, sharing, and reuse). Investigators face challenges
rapidly accessing integrated data sets in secure HIPAA-compliant analytic environments with support for data
annotation, reproducible analytics, and open access archiving and sharing. With social media, mobile apps, and
wearable devices, consumers are an additional collaborating partner. Cloud-based architectures offer new
opportunities to rapidly configure and deploy informatics technologies and analytic tools in a secure scalable
environment that “plays well” with external data partners, other CTSA Hubs, and the new CTSA Trial Innovation
Network. A new challenge is enabling the seamless movement of data between clinical, personal, and research
environments to support point-of-contact/personalized patient recruitment, real-time trial tracking, patientreported
outcomes, and continuous safety monitoring. True data liquidity requires integrating informatics tools at
the point of clinical care or patient interaction, including social media and eHealth environments, requiring new
relationships with institutional Health Information Technology (IT) operational partners, community-based
collaborators, and innovative Internet/social media/mobile-savvy companies. To date, the CCTSI Informatics
Pillar Program has fostered regulatory compliance and good data practices by enabling investigators to follow
best-practices via no-cost access to secure user-friendly data management services. Our current objectives
focus on linkages and workflows across operational, scientific (biological, clinical, population), patient/family, and
consumer data owners to maximize data liquidity from any source to any place at any time while maintaining
robust security, compliance, and confidentiality controls. We will achieve these goals through the following
Specific Aims: Aim 1:We will link and harmonize administrative, biological, clinical, and public health data using
our existing NIST 800-53 compliant secure research data warehouse data integration pipelines to create rich
longitudinal data assets specifically to support broad-scale translational research. Aim 2:We will implement new
infrastructure that supports data sharing and reproducible research. Aim 3: We will integrate the research data
lifecycle into clinical-care practice and in patient-centered venues. Aim 4: We will expand our online educational
resources to highlight next-generation research data infrastructures, data standards and annotation,
reproducible research and data sharing best-practices. Eliminating barriers that separate clinical research and
clinical care systems is necessary to “close the loop” with seamless participant notification and recruitment, trial
enrollment, efficient trial execution, and rapid dissemination of new translational discoveries, all within a data
secure and compliant environment. In collaboration with the new Trial Innovation Network, the Informatics
Program Aims are built around these objectives coupled with providing investigator education and support for
these new technologies.